Randomized trial of a leadership and organizational change strategy to improve the implementation and sustainment of digital measurement-based care in youth mental health services

PROJECT SUMMARY/ ABSTRACT
Psychiatric disorders are the leading cause of mortality and disability among youth in high income
countries, accounting for 21% of total disease burden, and afflicting 1 in 10 youths in the US with severe
impairment. Over 1,200 effective interventions, or evidence-based practices (EBPs), have been shown to
improve the well-being of youth with psychiatric disorders. However, despite these advances, less than half of
youths treated in community settings experience symptom improvement, a situation largely attributed to the
low rates at which community providers adopt EBPs and, even when adopted, the low fidelity with which EBPs
are implemented and sustained. Digital measurement-based care (MBC) systems, which collect treatment
outcome data from patients and provide clinicians with real-time feedback and recommendations based on ‘big
data’ actuarial algorithms, are a high-impact digital health technology EBP shown in 29 RCTs to generate
improvements in clinical outcomes (i.e., d=.3-.5) across patient ages, diagnoses, and treatment modalities.
Despite this, digital MBC systems are rarely used in community settings for youth, and when they are, fidelity
and sustainment are often poor. Recent reviews indicate that many of these implementation and sustainment
deficits can be traced to a lack of organization-level ‘social infrastructure’ or social contexts and leadership that
do not support and motivate clinicians to adopt and use MBC systems; without this organizational social
infrastructure, many implementation efforts fail. These observations are consistent with organizational climate
theory and theories of behavior change which we have integrated to generate our primary hypothesis:
achieving effective implementation and sustainment of MBC in community settings requires mechanisms of a
strong organizational implementation climate and high clinician motivation generated through effective clinic
leadership. With NIH support, we have pilot tested a highly transportable implementation strategy called
Leadership and Organizational Change for Implementation (LOCI) that targets these mechanisms. Preliminary
studies in mental health clinics show that LOCI is feasible, acceptable, and improves implementation
leadership and climate. We propose a randomized controlled trial of LOCI in 20 children’s mental health clinics,
incorporating 120 clinicians and a total of 720 youth outpatients, to test LOCI’s effects relative to
implementation as usual (IAU) on clinician fidelity and youth clinical outcomes of a well-established digital MBC
intervention during two phases of initial implementation and sustainment.
This project brings together an early career/new investigator (Williams) collaborating with experienced, NIH
funded implementation scientists (Aarons, Ehrhart) to advance programmatic research on the leadership,
organizational, and clinician mechanisms that improve digital MBC implementation and sustainment. The study
will (1) test LOCI’s effects on clinician fidelity to MBC and youth clinical outcomes during initial implementation,
and (2) sustainment; and (3) test the multilevel mechanisms that link LOCI to MBC fidelity.

Public health relevance
PROJECT NARRATIVE High-impact, evidence-based, digital health technologies, such as measurement-based care (MBC) software applications, can dramatically improve the outcomes of behavioral health service systems for youth on a national scale. However, the implementation and sustainment of MBC in youth service settings is stifled by deficits in effective leadership and the development of organizational social contexts necessary to support MBC implementation and sustainment. This project will test an implementation strategy that can be embedded in real-world settings to increase specific, modifiable, leadership and clinician behaviors that contribute to successful MBC implementation, sustainment, and clinical outcomes for youth. The project will improve youth behavioral health by advancing the integration of high-impact digital health technologies into routine, publicly- funded behavioral health systems.